Investigating labdane-related diterpenoid biosynthesis

Project Summary/Abstract
Natural products have a proven record of providing a significant fraction, either directly or as lead
compounds, of human medicines. Among natural products, the terpenoids (isoprenoids) stand out as
being the largest class (>80,000 already known), with the labdane-related diterpenoids (LRDs) that are the
focus of our studies forming a significant fraction of these (>7,000 known). Notably LRD biosynthesis
further models that of all terpenoids more generally, as the relevant diterpene cyclases and diterpene
synthases are phylogenetically and mechanistically related to the oxido-squalene cyclases and terpene
synthases from triterpenoid and smaller (mono-, sesqui- and other di-) terpenoid biosynthesis
(respectively). More concretely, the extensive diversification of LRDs indicates that the manifold
hydrocarbon skeletons that can be formed around the characteristic decalin core ring provides privileged
scaffolds for derivation of biological activity. Indeed, a number of these LRDs are used as pharmaceuticals
(e.g., the novel mutilin antibiotics derived from pleuromutilin) or are being investigated for such use (e.g.,
the tanshinones), while others serve important roles in widely grown crops (e.g., rice), such that
engineering their biosynthesis may enable reduced agrochemicals application and, hence, improve food
and environmental safety. Accordingly, we propose here to continue our productive studies of the enzymes
required to produce LRDs. Specifically, we will build on our previous work in this area, which includes
investigations of enzymatic structure-function that have provided novel biosynthetic access to an array of
LRD backbones, such as those relevant to production of pleuromutilin, as well as further elucidation of the
complex LRD metabolism in rice, which serves as a model system for the extensive diversification of these
natural products throughout cereal crop plants more generally, and which we have shown play key roles
as antibiotics against microbial pathogens as well as parasitic nematodes. This MIRA renewal proposal
covers our systematic studies in this general area, advancing our long-term goal of engineering enzymes
and metabolic pathways for production of targeted libraries and specific individual LRD ‘natural’ products,
several of which are already in medical use and the utility of which in crop engineering for improved
environmental and, hence, human health is already being realized.

Public health relevance
Project Narrative The labdane-related diterpenoids form a very large class of natural products (>7,000 known), which includes several of realized (e.g., pleuromutilin) or potential (e.g., triptolide) pharmaceutical use, along with a virulence factor produced by the human pathogen Mycobacterium tuberculosis, as well as others of importance in critical crop plants such as rice. Here we propose to continue our fruitful investigations of the enzymes that produce these natural products. This will not only increase our understanding of the relevant enzymatic mechanisms, but also enable engineering of such biosynthesis to increase access to these often-scarce natural products.